CORE A (Administrative Core)

ABSTRACT/SUMMARY – Core A (Administrative Core)
The Administrative Core (AC) is based in the Sylvester Comprehensive Cancer Center (Sylvester) at
the University of Miami Miller School of Medicine. The principal investigator of this P01, Wael El-Rifai, MD,
PhD, is the Director of AC and is responsible for the activities of this core. The AC establishes and executes
the scientific and organizational direction and strategy; provides fiscal and administrative oversight,
coordination, and operations management; provides information technology resources to support the research
development and dissemination processes; and assesses the effectiveness and impact of the P01 research
projects and its individual cores. The AC is responsible for managing the P01 resources and facilitating
communications between the P01 components, other collaborators, and with the NCI. This is accomplished
through a series of oversight committees, organized administrative and scientific meetings of P01
investigators, institutional representatives and external advisors. The AC provides organizational structure for
managing the P01 resources and facilitating communications between the P01 components, other
collaborators, and with the NCI. The organizational structure of AC includes two committees to ensure a broad
range of expertise and input into the management process. These include the: 1) Institutional Advisory Board
(IAB), and 2) External Advisory Board (EAB). The AC structure has included several opportunities for scientific
interactions. These include a bi-weekly meeting of project leaders and core directors, weekly laboratories’
research meetings and discussion, a bi-weekly research seminar, a bi-weekly journal club, and an annual
retreat and symposium. In addition, the AC is also responsible for management of communications within the
P01 and between the P01, the Sylvester’s Tumor Biology Program, and the NCI. This will be accomplished
through e-mail, fax, standard mail, and an online web site. Committee reports will be distributed to P01
investigators via these media. Communication to the press, both internal and external, will also be coordinated
through this core. In summary, the AC facilitates key communication, monitoring and oversight services using
built-in committees and measures for accountability, fiscal management, monitoring and evaluation of the
performance of projects and cores.

Public health relevance
NARRATIVE The Administrative Core is responsible for managing the P01 resources and facilitating communications between the P01 components, other collaborators, and with the NCI. This is accomplished through a series of oversight committees and scientific meetings.